Impact of Improvisation Music Therapy for Persons Living with Dementia and their Care Partners

Abstract
Alzheimer’s disease and related dementias (AD/ADRD) affect more than 6 million adults over 65, with family
members providing most of the care for persons living with dementia (PLWD). During AD progression,
behavioral and psychological symptoms of dementia (BPSD), like agitation, anxiety, and depression, are
common. This can lead to stress and depression among care partners. Thus, interventions must be developed
to aid both members of the PLWD-care partner dyad. Music-based interventions are effective, non-
pharmacological treatments that reduce BPSD in PLWD and care partner stress. However, most existing
music-based interventions target only the PLWD or the care partner, but not both dyad members
simultaneously. Improvisation music therapy is a type of music therapy that uses creative and meaningful
musical exchanges to move patients toward emotionally desirable states. Improvisation music therapy
promotes rapid and novel idea generation, emotional awareness, and execution of unplanned motor
sequences. For these reasons, improvisation music therapy may be able to reduce stress through emotion
regulation in PLWD-care partner dyads. The candidate’s long-term goal is to become an independent
investigator who examines mechanisms by which music-based interventions improve health and well-being
among PLWD and their care partners. For this career development award, the candidate’s short-term goal is
to investigate the impact of an improvisation MT intervention prototype on behavior change (BPSD reduction in
the PLWD, increased well-being and decreased burden in the caregiver) through stress reduction. The
proposed research project aims to 1) standardize an improvisation music therapy intervention prototype for the
PLWD-care partner dyad, 2) evaluate the feasibility and acceptability of this intervention, and 3) complete a
pilot study to examine whether stress reduction and emotional regulation are potential mechanisms for positive
behavior change. This K01 project combines a rigorous research program, mentorship, and didactic goals.
The career training goals will help the candidate acquire: 1) content expertise in ADRD, 2) knowledge about
behavioral intervention standardization using the NIH Stage Model, NIH Science of Behavioral Change, and
mixed methods design, 3) content expertise in dementia caregiving, 4) experience on rigorous clinical trial
design, analysis, and management, and 5) academic leadership and research skills necessary for becoming
an independent academic researcher. At the project's conclusion, the proposal will have standardized a novel
intervention prototype for PLWD-caregiver dyads based on improvisation music therapy. The pilot study will
expand knowledge of how and why music therapy facilitates well-being for both PLWD and care partners.
These results will inform a future R01 to conduct a powered, randomized clinical trial of music-based
interventions to improve emotion and well-being outcomes in PLWD-care partner dyads that may ultimately
lead to long-term, downstream effects such as improved quality of life.

Public health relevance
Project Narrative Behavioral and psychological symptoms of depression (BPSD) often develop during the progression of Alzheimer’s Disease and related dementias, which affects the well-being of family care partners. A critical need exists to reduce BPSD in persons living with dementia and to reduce care partner stress. This project proposes to standardize a prototype of an improvisation music therapy intervention for both the person living with dementia and the care partner (i.e. the dyad), test the feasibility and acceptability of the intervention, and perform a pilot study to examine whether emotion regulation and stress reduction are potential mechanisms for positive behavioral change in persons living with dementia and their care partners.